Developing entrepreneurial skills for the BIOCLIN software platform to support biomarker clinical trials

Genomic biomarkers enable precision medicine by matching patients to their optimal
treatments. Mutational biomarkers are used as standard practice for oncology patients to
assign them to treatment. However, mutations don’t have the predictive power for several
therapies, including immunotherapy, which results in complete and durable responses for
a subset of cancer patients. RNA sequencing (RNAseq) has been shown to improve
accuracy over mutations in preclinical studies, including being able to predict response to
immunotherapy, and even mutational status. The global RNAseq market is currently
estimated at 9 billion dollars and is expected to grow at an annual rate of 10% from 2023 to
2030. The number of RNAseq biomarker trials has already doubled in 2020-2023 compared
to 2010-2020, based on data in clinicaltrials.gov. RNAseq biomarkers currently face three
major challenges: (1) bioinformatics analysis to translate signatures, cutoffs, etc. for
application in the clinic, (2) regulatory issues with reproducibility and clinical validation,
and (3) lack of software platforms to provide clinical trial support for biomarkers. There is
currently no commercial software to support patient selection based on their RNAseq
profiles at baseline, to the best of our knowledge.
We have developed a prototype software suite, BIOCLIN, for an ongoing multi-site
phase II RNAseq biomarker trial in kidney cancer (NCT05361720). It includes analysis of
RNAseq data for each patient on the fly, run machine learning models and display gene
signature scores per patient in an easy to use, intuitive user interface. Our goal is to
develop our prototype into a commercial product with additional functionality that
can be used to rapidly deploy platforms to support biomarker-based trials.
In this proposal, we are applying for our three-person team to participate in the ICorps
program to learn more about successful commercialization strategies for our product,
BIOCLIN.

Public health relevance
PROJECT NARRATIVE RNA sequencing data yield powerful biomarkers for precision medicine, however there is a gap in the lack of software platforms to facilitate testing such biomarkers in the clinic. Our proposal is to develop methods to translate preclinical RNAseq biomarkers for clinical use, and to develop a comprehensive set of backend cloud-based infrastructure to enable rapid deployment of software platforms to support biomarker-driven trials. Our platform will address a much-needed solution to advance precision medicine.